Diversity Supplement: Deep cell history tracking: engineering cells that write their detailed life stories into their DNA to study DNA damage

Abstract from Parent Grant
DNA recording is a recently developed technology that allows cellular signaling events of interest to be
followed over time without removing cells from their physiological context. During a DNA recording
experiment, genetically engineered cells expressing the DNA recorder acquire mutations at a “recording
locus” as the result of transient cellular events, without perturbing their normal phenotype. At the end of the
experiment, once their eventual phenotype is known, cells can be collected and their histories determined
by sequencing the recording locus. The work proposed here will lead to a DNA recorder that is not limited,
as current technology is, to recording one or two cellular events per experiment, but can record dozens of
events in parallel, allowing an unbiased examination of cell history in any context compatible with
genetically engineered cells. In this project, the new DNA recorder will be used to study long-term effects
for a cell of experiencing significant spontaneous DNA damage. Although DNA damage is very well studied,
it has not previously been possible to follow the rare cells that experience significant spontaneous
damage, especially in an in vivo mammalian context. The new DNA recorder will be developed in stages:
First, intracellular recording machinery, will be created for a small number of cellular events associated
with the DNA damage response. Next, the fidelity of this new recording machinery will be extensively
validated in cultured cells, including head and neck cancer cells becoming resistant to the DNA-damaging
chemotherapeutic cisplatin. Finally, the recorder will be validated in mouse embryonic stem cells, and used
to test how spontaneous DNA damage affects cell fate determination during the earliest stages of
development.

Public health relevance
Every time cells divide; their DNA is damaged at a low level. This “endogenous” DNA damage is an important factor in normal and aberrant animal development, but because it happens at a low level over long time periods it hasn’t been possible to study in detail. I propose to develop a new tool with the resolving power to study endogenous DNA damage and other rare cellular processes over weeks to months in developing mammals.